Inflammasome activation in trauma-hemorrhagic shock

PROJECT SUMMARY/ABSTRACT
Controlling inflammation and cellular damage is key to preventing and treating multiple organ failure
(MOF) following trauma. However, many of the mechanisms that regulate inflammation and cell death in
specific organs remain unknown. So despite advances in supportive care for MOF patients, there have been
few advances in MOF treatments, or in our ability to adequately prevent MOF onset. Our overarching goal is
to ultimately develop new therapeutics for trauma patients based on regulating inflammatory responses and
effects on cell death following trauma and hemorrhagic shock with resuscitation (HS/R). In this proposal we
will continue to investigate downstream cell and tissue-specific effects of caspase-4 (human)/11 (mouse)
activation after HS/R. We will also assess the ability of a novel caspase-4/11 inhibitor to reduce HS/R-
mediated effects on systemic inflammation, cell death and end-organ injury. Understanding the multiple effects
of caspase-11 on inflammation and organ damage will enable us to assess the translational potential of
targeted caspase-11-inhibition for improved patient outcomes after trauma and hemorrhage.
The most recent work on this grant defined a novel mechanism of caspase-4/11 activation (non-
canonical inflammasome) in trauma/HS/R. Caspase-4/11 is the intracellular receptor for lipopolysaccharide
(LPS) and is an important mediator of inflammation during infection and sepsis. Our work showed activation of
caspase-4/11 in non-LPS-driven models of inflammation, and we defined a novel mechanism of activation of
caspase-11 by endogenous oxidized cardiolipin (CLox) on the outside of stressed mitochondria. CLox is
regulated by cytochrome c, and specific inhibition of cytochrome c inhibits caspase-11 activation and is highly
organ protective in a mouse model of HS/R. However, the mechanistic basis of detrimental effects of caspase-
11 activation in HS/R are not clear, and may be multifactorial given its multiple cell-specific inflammatory
effects, including induction of pyroptosis (inflammatory cell death), active release of inflammatory HMGB1 in
extracellular vesicles (EV) from hepatocytes after HS/R, and more recently-described effects on coagulation
through enhanced binding of tissue factor (TF) on endothelial cells (EC) in sepsis. Therefore, our main
hypothesis is that caspase-4/11 activation is detrimental during HS/R through multiple cell-specific
effects. In this proposal we will: 1: determine the role of caspase-4/11-mediated inflammation on organ
injury during HS/R; 2: determine the effects of caspase-4/11-activation on coagulation and organ injury
during HS/R; 3: determine safety and effectiveness of caspase-11-specific inhibition in mouse models
of HS/R. We expect to show specific inhibition of caspase-4/11 in HS/R is organ protective and the
mechanisms of protection are multi-factorial. We also expect to show inhibition of caspase-4/11 is an attractive
therapeutic target to reduce trauma-induced inflammation, coagulopathy and organ damage.

Public health relevance
PUBLIC HEALTH RELEVANCE Trauma and shock activate pathways of inflammation that can lead to organ failure and death. The mechanisms of activation of inflammation in different organs and cell-types is not well understood, but knowing how cell, tissues and organs respond to shock may improve our future ability to prevent and treat organ failure in trauma patients. Our research investigates effects of activation of an inflammatory protein, caspase-11, on organ damage and inflammation during shock, and investigates inhibition of caspase-4/11 as a treatment approach to prevent organ failure in severely injured patients.